Mechanistic Monitoring of Ultrasound Neuromodulation

Central Nervous System diseases affect several millions of patients in the U.S. Current drug
treatments are often associated with side-effects such as dyskinesia, confusion, dizziness,
insomnia, depression, and pathological gambling among others. Neuromodulation can be
achieved either with noninvasive techniques that are depth limited or invasive procedures that
can go to large depths. Over the past few years, transcranial focused ultrasound (FUS) has been
shown capable of both stimulating and suppressing brain activity in vivo. Ultrasound has several
advantages over the aforementioned technologies for deep brain stimulation as it can penetrate
the brain over several centimeters through the intact scalp and skull. Given its entirely noninvasive
and nonionizing nature, the technique has been shown to be translatable to human brain studies
with deep penetration (of several centimeters) without requiring introduction of electrodes or optic
fibers inside the brain. In the proposed study, we will aim to harness from the technical expertise
available by the group of investigators so as to develop monitoring of the underlying physical and
physiological mechanisms in vivo and in real time and simultaneously sync technologies that will
allow translation to humans. The three physical mechanisms to be investigated are radiation
force, cavitation and perfusion, all of which can be monitored in conjunction with FUS modulation
by the PI’s group. Therefore, the underlying hypothesis of the proposed studies is that if these
underlying mechanisms, or the combination thereof, can be monitored during application, FUS
can be more targeted and better monitored to improve on its reproducibility and optimization. To
this end, we have assembled a highly complementary, multi-disciplinary team from ultrasound
engineering, anatomical and functional imaging, neuroscience, neurology, neuroengineering and
neurosurgery. The methodologies proposed require breakthroughs in current FUS methodologies
used in order to selectively focus (on the order of a few millimeters) and steer across both shallow
and deep-seated regions (on the order of several centimeters in depth) as well as informing on
the physical (i.e., radiation force or cavitation - mechanical tissue effects exerted by ultrasound
on the brain) and physiological (i.e., neuronal effects as a result of the aforementioned mechanical
tissue effects) mechanism in real time. This study is thus aimed to optimize targeting and efficacy
of FUS neuromodulation by mapping the physical mechanism so as to better explore noninvasive
modulation of motor and motivation responses in humans for the first time for the ultimate
treatment of conditions ranging from movement to psychiatric disorders.

Public health relevance
Central Nervous System diseases affect several millions of patients in the U.S. Current drug treatments are often associated with side-effects. Neuromodulation can be achieved either with noninvasive techniques that are depth limited or invasive procedures that can go to large depths. Focused ultrasound offers the unique alternative of modulating deep-seated structures noninvasively. In this study, we will develop novel tools to assess ultrasound modulation by monitoring the effects of ultrasound on brain tissue.